Mechanisms of neurodegeneration by a fibrinogen-containing protein complex during traumatic brain injury

Project Summary
This application addresses problems related to vascular cognition impairment (VCI). Particularly it aims to define
mechanisms of vasculo-astrocyte functional connectivity that results in cognitive decline after inflammatory
pathologies, e.g. traumatic brain injury (TBI). It is known that increased vascular permeability is involved in
pathological alterations in neurovascular network such as accumulation of fibrinogen (Fg) and cellular prion protein
(PrPC) leading to neuronal dysfunction and degeneration. However, critical factors that initiate these effects are not
known. Our preliminary data indicated that TBI-induced an increase in blood level of Fg, called hyperfibrinogenemia
(HFg), and enhanced cerebrovascular permeability to proteins mainly via caveolar transcytosis. This effect caused
a greater deposition of Fg and increased formation of Fg and PrPC complex in vasculo-astrocyte interface, resulting
in vasculo-astrocyte physical uncoupling and astrocyte activation leading to neuronal degeneration via
overexpression of neurotrophic tyrosine receptor kinase B (TrkB) and formation of reactive oxygen species (ROS).
These effects were associated with neuronal degeneration and reduction in short-term memory (STM) in mice after
TBI. Importantly, treatment of mice with siRNA against caveolae membrane protein caveolin-1 (Cav-1) ameliorated
TBI-induced memory reduction. Based on these data, we propose a novel hypothesis that TBI-mediated
inflammation increases the blood level of Fg, which via binding to endothelial ICAM-1 activates caveolar protein
transcytosis resulting in enhanced Fg deposition and formation of Fg-PrPC complex, which cause astrocyte
activation, vasculo-astrocyte uncoupling and subsequent neuronal degeneration (via TrkB-ROS pathway) resulting
in STM reduction. This compelling hypothesis provides the crucial link between vascular dysfunction and neuronal
degeneration leading to cognition impairment during various cerebrovascular pathologies. The present study
should reveal the fundamental, previously unknown mechanism for vasculo-astrocyte uncoupling (altered
functional and physical connectivity) leading to neuronal degeneration and memory reduction after TBI. The
hypothesis will be tested with three specific aims: (1) To define whether the HFg-mediated caveolar protein
transcytosis enhances Fg deposition and Fg-PrPC complex formation in brain extravascular space during TBI. (2)
To define whether the Fg-PrPC complex formation in vasculo-astrocyte interface causes vasculo-astrocyte
uncoupling and neuronal degeneration leading to reduction in STM during TBI. (3) To define if diminishing caveolae
formation in vascular endothelium and Fg-PrPC complex formation can ameliorate neuronal degeneration and STM
reduction during TBI. Specific mechanisms of TBI-induced vasculo-astrocyte uncoupling and memory impairment,
i.e. VCI, will be studied using cultured endothelial cells and astrocytes, and C57BL/6J wild type and transgenic HFg
mice. Fg-PrPC complex and ROS formations, levels of TrkB, astrocyte activation, and neuronal degeneration
assessed by NeuN will be evaluated by immunohistochemistry and Western blot. STM will be assessed by novel
object recognition test, Barnes maze and Y-maze tests.

Public health relevance
Project Narrative Increased cerebrovascular permeability is a major contributing factor to the morbidity and mortality during inflammatory diseases (e.g. traumatic brain injury (TBI)) that are accompanied with increased blood content of fibrinogen (Fg). The latter increases cerebrovascular permeability, deposits in extravascular space and by forming degradation resistant complex with cellular prion protein (PrPC), detaches astrocyte endfeet from vessels leading to reduction in short-term memory (STM). As we address mechanisms of this process, the proposed study will reveal a novel pathogenic causal relationship in TBI-induced vasculo-neuronal dysfunction and STM impairment.